Neuroscience Training Program

Start with Principal Investigator. List all Name Tranel, Daniel city, state) Use continuation pages as needed to provide the required information in the format shown below. other key personnel in alphabetical order, last name first. Organization Role on